Strategic Training Partnership to End AIDS in Georgia

The Georgian nongovernmental organization Partnership for Research and Action for Health
proposed to partner with the Ivane Javakhishvili Tbilisi State University (TSU), in collaboration
with the State University of New York Downstate Medical Center and the State University of
New York Albany School of Public Health (UAlbany SPH) along with other New York State
institutions to build capacity in conducting implementation science research that will address
gaps in HIV prevention and care in Georgia. This effort builds on the long and productive
association between Georgian universities and public health institutions, SUNY-DMC and
UAlbany SPH, within the framework of the Fogarty funded New York State International Training
and Research Program (NYS-ITRP) training grant that has been active in Georgia since 1996.
The goal is to develop adequate capacity to better understand key barriers to HIV
testing/diagnosis and linkage to care among key populations and to prepare an evidence base
to improve the national response to HIV. Proposed objectives includes:1) Provide doctoral
training in public health and implementation science to 10 Georgians, who will be trained in the
US and in Georgia; 2). Provide short-term training to 30 trainees in sciences related to
implementation research annually; 3) build institutional capacity at TSU through doctoral course
improvement and faculty training. With progress in these interventions, it may be possible to
dramatically reduce HIV incidence in a country of the former Soviet Union, one of the few
regions in the world with rising HIV rates. The proposed structure, topics, and focus were
selected based on a rigorous needs assessment conducted within the framework of a Fogarty
supported planning grant. These topics align fully with UNAIDS’s key recommendations to
policy makers on the investments needed to end the global AIDS epidemic and will be built on
an already funded CDC initiative to eliminate hepatitis C in Georgia. The program’s proposed
scientific topics also align fully with the priorities laid out in New York State’s “Plan to End the
AIDS Epidemic.” This alignment of priorities, as well as the underlying similarities in the HIV
epidemics in the Republic of Georgia and New York State, creates a unique opportunity to
incorporate a meaningful experiential learning component as part of the proposed training
program. This addresses a high priority topic from the NIH strategy on reducing the incidence of
HIV/AIDS by implementing strategies to improve HIV testing and entry into prevention services.

Public health relevance
HIV care continuum gap remains a major problem in the country of Georgia. To help improving national efforts for successful implementation of “End AIDS” strategy in the country this proposal to build capacity in conducting implementation science research that will address gaps in HIV care in the country. This addresses a high priority topic from the NIH strategy on reducing the incidence of HIV/AIDS by implementing strategies to improve HIV testing and entry into prevention services.